Chemical Proteomic Identification of Druggable Oncogenic Transcription Factors

Project Summary
Advances in human genetics have identified +400 genes that when amplified or mutated promote tumorigenesis.
While there has been huge success in developing drugs for kinases and metabolic enzymes deregulated in
cancer, they represent only a small fraction of the cancer drivers discovered to date. A major challenge in cancer
research is developing drugs for oncogenic drivers. The vast majority (~80%) of these cancer drivers remain
undrugged, including one of the largest classes, transcription factors (TFs) which account for ~19% of
oncogenes. These TFs are normally required during development, however, are hijacked during tumorigenesis
providing malignant cells with the plasticity required for unchecked proliferation. Although these oncogenic TFs
have been biologically credentialed, they are historically considered difficult to target with small-molecule
inhibitors, limiting the development of transformative cancer therapies. To overcome these challenges in cancer
drug discovery and address the clear unmet needs in cancer treatment, our lab adopts state-of-the-art chemical
proteomic platforms that both radically expand the druggable protein landscape in cancer and allow us to pinpoint
which proteins are amenable to small molecule inhibition. These chemical proteomic technologies combine the
specificity of chemical probes which only react with proteinaceous cysteines with the comprehensive analytical
scale of next generation proteomics. Cysteines play critical roles in protein function and are the targets of multiple
clinically approved inhibitors. By profiling their interaction with covalent drug-like fragments, we recently
discovered that a much larger extant of the proteome than originally predicted is amenable to covalent
druggability. While these chemical proteomic approaches have transformed our notion of which proteins are
druggable, they remain ill-equipped (due to sensitivity of detection) to determine cysteine druggability on low
abundance oncogenic transcription factors. In this grant application, we build on our core chemical proteomic
platform and incorporate advances in protein and organelle enrichment technologies to prosecute the
druggabilty of high-priority oncogenic TFs by developing two conceptually new and complimentary approaches:
1) By isolating chromatin bound proteins, we enrich for active TFs, enabling us to use traditional chemical
proteomic approaches to provide a high content map of druggable cysteines in oncogenic TFs. 2) We develop
Enrichment Cysteine Druggability Mapping (ECDM) which allows us to systematically immunoprecipitate and
enrich low-abundance TFs and rapidly interrogate the druggabilty of cysteines found in these factors in a period
of 18 minutes compared to 30 hours using standard approaches. The research proposed herein, takes full
advantage of advances in human genetics and functional genomics and combines them with ultra-high
throughput chemical proteomic technologies to define the druggability of TF cancer drivers, a critical first step in
the development of targeted therapies. If successful, the development of these drug-discovery platforms has the
potential to reshape the next-generation of targeted anti-cancer therapeutics.

Public health relevance
Project Narrative Transcription factors (TFs) encompass one of the largest classes of oncogenes and are deregulated in multiple cancers. However, TFs are conventionally considered difficult to target with small molecule inhibitors, limiting the development of transformative cancer therapies. The goal of this application is to develop advanced chemical proteomic platforms to expand the druggable proteome and identify which oncogenic TFs are amenable to small molecule inhibition, laying the ground work for developing pharmacological agents against these factors.